Fine-tuning CXCL12-mediated activities using Beta1-strand binding peptides

ABSTRACT
The CXCR4/CXCR7-CXCL12 signaling critically modulate immune and cancer cell functions. Our work and
others have established the presence and the potential of chemokine heterodimers especially CXCL4-CXCL12
associated with an inhibition of CXCL12-CXCR4 signaling suggesting a new regulatory targetable mechanism.
The biological consequences of these newly discovered interactions including of CXCL4-CXCL12
heterodimers with CXCR7 have not been studied yet. Further, whether CXCL4-CXCL12 chemokine hetero-
dimerization may serve as a therapeutic target to prevent CXCL12-driven cell function is unknown.
Therefore, we will test the hypothesis that CXCL12 ß1-strand binding peptides, mimicking the CXCL4
interface with CXCL12, critically affect signaling and biological activities in well-delineated CXCL12-CXCR4/
CXCR7 driven signaling. Specifically, we will determine the inhibiting potential of CXCL12 ß1-strand binding
peptides in the CXCL12-CXCR4/CXCR7 driven signaling in macrophages and epithelial cells. The non-
overlapping specific aims of the study will define binding characteristics and optimize the CXCL12 ß1-
strand binding peptides (Aim 1); and determine the functional signaling modulating potential of CXCL12
ß1-strand binding peptides onto CXCR4 and CXCR7 (Aim 2), respectively. We will assess the CXCL12-
CXCL12 ß1-strand binding peptide heterodimer signaling onto CXCR4 and CXCR7 associated functional
activities on key cell functions, along with the optimal biophysical conditions promoting stable CXCL12-
CXCL12 ß1-strand binding peptide interactions and the potential of specific CXCL12 ß1-strand binding
peptides to inhibit CXCL12-CXCR4/CXCR7 signaling and modulate CXCL12-driven cell functions.
Together, the data gathered through the completion of the experiments associated with the completion of the
proposed aims will yield a better understanding of the CXCL12 heterodimer signaling onto CXCR4 and
CXCR7 and the potential of CXCL12 ß1-strand binding peptides in preventing altering CXCL12-driven
signaling and functions. Building on these results and targeting heterophilic interactions of chemokines,
our long-term goal is to develop a fundamental understanding of the functions of chemokine
heterodimers in chemokine signaling and their potential as target to prevent disease progression. This AREA
project will expose undergraduate students to an integrative and cross-disciplinary research environment by
extending training opportunities in the Departments of Biological Sciences and Physics and Optical Sciences at
the University of North Carolina Charlotte, a rapidly-growing urban institution that seeks to strengthen its
biomedical research program. This project has already attracted many undergraduate students through the PI’s
and co-I’s classroom teaching and will further provide undergraduates a hands-on experience with laboratory
research techniques and introduce them to a career in biomedical research. Students will participate in peer-to-
peer training at all levels, including an emphasis on skills needed for professional success such as teamwork
and communication.

Public health relevance
PROJECT NARRATIVE The focus of this proposal is CXCL12 ß1-strand binding peptides mimicking heterodimerization in chemokine signaling and function and relevance in pathologies including cancer and inflammation, and therefore, is directly related to public health. Extensive research has demonstrated the key roles of CXCL12 chemokine monomers and homodimers in cell-cell communication, and our recent data support a role for CXCL4-CXCL12 heterodimers bound through ß1 strand interface, however, the presence and activities of CXCL12 ß1-strand binding peptides mimicking CXCL12 heterodimerization in CXCL12-driven signaling and key cell functions has not been investigated. The proposed studies are essential to define the potential CXCL12 ß1-strand binding peptides mimicking heterodimerization in modulating CXCL12-CXCR4 and CXCL12- CXCR7 signaling including cell activities in diseases such as both cancer and inflammation; long-term, this knowledge will contribute not only to the basic understanding of chemokine signaling cell communication but also lead to improved and new targeted therapeutic approaches.